ISSUES AND OUTCOMES OF ACUTE SPINAL CORD INJURY FOLLOWING LATE ONSET

The purpose of this study is to determine how various medical and psychosocial outcomes following spinal cord injury differ between individuals older than age 55 to those 18-34 years of age.